Yale Cancer Biology Training Grant

Recent advances in understanding cancer, combined with unprecedented access to patient DNA
sequence data, and new rational therapeutic approaches create the need for a revolution in Ph.D. training of
cancer scientists. The Yale Cancer Biology Training Program takes advantage of the high caliber of biologists
at Yale, the commitment to multidisciplinary training in the life sciences, and the close collaboration of Yale
cancer biologists and clinicians fostered by the Yale Cancer Center to provide a cancer-focused training
experience that is intended to spawn the next generation of cancer scientific leaders. This program is the only
cancer-focused PhD training program at Yale and is also unusual in the extent of exposure to clinical concepts
and practice. Training will cover the genetic and biological underpinnings of cancer, the pathway to
development of new therapies based upon this knowledge, and the practical challenges in applying these new
therapies in cancer clinics. Predoctoral trainees will be trained in foundational biological areas through course
work in fundamental areas including biology, genetics, computational biology, and pathophysiology and join the
program in the second year of graduate school. Postdoctoral fellows will join the program early in postdoctoral
training. All trainees will spend 90% of their time in laboratory research projects mentored by highly qualified
faculty who are leaders in disciplines of cancer research including tumor virology, cancer immunobiology,
cancer genetics and epigenetics, stem cell research, metabolism, pharmacology, and signal transduction.
This two-year program will train up to 30 predoctoral and postdoctoral trainees each year (including first
and second year trainees). Funding for two predoctoral and six postdoctoral trainees will be supported by this
training grant. For predoctoral trainees, the training experience will include three research rotations and
didactic and seminar courses and continue with qualifying examinations and written dissertation in a projected
period of five years overall. Postdoctoral training includes participation in program coursework and other
program activities. All trainees are supervised by faculty committees that meet annually to evaluate research
progress and promote training goals and career development. Cancer-specific training provided for all trainees
will include three formal courses: 1. a general survey class covering basic principles of cancer biology and
genetics; 2. Advanced Topics in Cancer workshop in which selected topics are analyzed and discussed in
depth; 3. Cancer Clinical Translation, including practical clinical translation, clinical trials, and patient treatment
patterns and clinical questions for major diseases. Multiple options are provided for training in Immuno-
Oncology, depending on prior immunology background. Other program elements include Precision Medicine
Tumor Board (discussion of cases in the context of whole genome tumor sequence), Yale Cancer Center
Grand Rounds and Program Meetings, and Cancer Biology Training Program meetings. Every trainee will have
a clinical mentor to foster exposure to clinical concepts through tumor boards and clinics.

Public health relevance
The Cancer Biology Training Program provides training in translational cancer research for predoctoral and postdoctoral PhD trainees who will become leaders in cancer investigation leading to major improvements in cancer therapy. The program capitalizes on the depth and quality of cancer research and clinical efforts at Yale, including a significant commitment to therapeutic translation. Seasoned PhD trainers working in close collaboration with clinical mentors will provide rigorous training in fundamental biological principles combined with a focus on cancer scientific and clinical challenges.